Molecular Pathogenesis of Acute Myeloid Leukemia

Project Summary
The long-term goal of this project is to develop effective, precision therapies directed against the
initiating mutations of Acute Myeloid Leukemia (AML). During the current funding period, we performed a
series of genomic and epigenomic studies that have clarified the mechanisms that AML initiating mutations use
to "reprogram" hematopoietic stem progenitor cells (HSPCs), increasing their fitness for transformation. In the
next funding period, we will use primary human AML samples, induced pluripotent stem cells (iPSCs),
and genetically engineered mouse models to further evaluate the molecular mechanisms involved in
preleukemic reprogramming, and progression to AML. Four well characterized events (that initiate more
than half of AML cases) will be studied in detail. We will continue our work with DNMT3A mutations and PML-
RARA, and add the study of Core Binding Factor AML fusions (RUNX1-RUNX1T1 and CBFB-MYH11). The
"toolkit" for these studies will involve the analysis of preleukemic and fully transformed hematopoietic cells from
these models, using bulk DNA and RNA sequencing, whole genome bisulfite sequencing, ATAC-seq, ChIP-
seq and/or CUT&RUN to detect the genomic locations of activating and repressive histone marks (and the
fusions themselves), and single cell technologies for RNA, DNA, and ATAC-seq. We will also be performing
comprehensive proteomic studies to complete "proteogenomic" datasets for these initiating events,
including 1) the identification of the hematopoietic proteins that interact with the initiating proteins
listed above, and 2) the development of quantitative deep-scale proteomic and phosphoproteomic
datasets broadly representative of all AML subtypes. The integrative analysis of these datasets (and their
availability to the AML community) should provide important new insights about AML pathogenesis, and
suggest mechanistically targeted therapies. In this proposal, we provide one representative example of this
process: using novel methods to identify proteins that interact with DNMT3A, we discovered several mutations
that disrupt the normal interaction of DNMT3A with an inactive isoform of DNMT3B (DNMT3B3); these
mutations destabilize DNMT3A and decrease its activity. Remarkably, we found that we can restore the activity
of many mutant DNMT3A proteins by retrovirally overexpressing DNMT3L, a protein that normally interacts
with DNMT3A and 3B in embryonic cells to increase their activity. "Addback" of DNMT3L into hematopoietic
cells with the Dnmt3aR878H mutation remethylates DNA, and decreases the growth of AML cells initiated by this
mutation. Since DNMT3L is epigenetically silenced in nearly all AMLs, a program to identify drugs and genetic
strategies to reactivate DNMT3L in AML cells will be developed. We have already found that Romidepsin, an
HDAC1 inhibitor, potently induces DNMT3L expression, and a clinical trial designed to evaluate the activity of
this drug in DNMT3A mutant AMLs is planned. Additional approaches for developing mechanistically driven
therapies designed to thwart initiating mutations will be developed during the next funding period.

Public health relevance
Project Narrative Acute Myeloid Leukemia (AML) is a devastating hematopoietic malignancy that is fatal for most of the patients who develop this disease. In this proposal, we will develop and analyze comprehensive genomic, epigenomic, and proteomic databases using samples from AML patients, and genetically defined mouse models with common AML initiating events. The long-term goal of this project is to use these datasets to develop effective, mechanistically-driven therapies directed against the initiating mutations of this disease.